TX OF ENDOTHELIAL DYSFUNCTION IN PATIENTS WITH CORONARY ATHEROSCLEROSIS

This protocol will study whether abnormal coronary vasomotion can be reversed by therapy to lower cholesterol. Restoration of endothelial function will be represented by the return of endothelium-dependent dilation to acetylcholine with the reversal of paradoxical constriction.